Temporal responses in host-virus interactions

PROJECT SUMMARY
In addition of being at higher risk for developing chronic disease, elderly individuals are more vulnerable
than younger adults to infectious diseases, including viral infections, and often exhibit higher incidence, severity
and mortality rates. Despite numerous advances in understanding the interactions between viruses and their
hosts, we lack knowledge about the processes underlying these relationships as a function of age. With the
unprecedented numbers of older individuals on the planet, a major goal is to ensure appropriate preventive and
treatment strategies leading to a longer, healthier life. Consequently, there is great need to unravel the
fundamental mechanisms that lie beneath the capability of the aged organism to survive infection.
In this application, we propose to use the model organism Drosophila melanogaster to investigate the
mechanisms that contribute to age-dependent survival of infection with an RNA virus. Precisely, we will use a
combination of genetic and molecular approaches to 1) investigate the role inflammatory NF-kB pathways play
in immunopathology associated with viral infection at older age 2) conduct functional analysis of a set of
evolutionarily conserved genes with no previously reported role in antiviral immunity. Our experiments will focus
on studying the role of infection tolerance mechanisms as an age-dependent anti-viral defense strategy. We will
also seek to determine how the evolutionarily conserved NF-kB inflammatory pathway and possibly other cellular
pathways are implicated in the impaired ability of the older host to survive virus infection. This will be done by
examining age-dependent outcomes of infection in several mutants for components of the Drosophila IMD NF-
kB pathway and in fly lines in which novel candidate genes are being knocked down or overexpressed. Because
the underlying genetic and molecular mechanisms are likely to be conserved from flies to humans, we expect
these studies to provide important new insights filling the knowledge gap about the interactions of viruses and
their older hosts. Our studies could potentially lead to future therapeutic improvements for infected elderly
patients. The proposed project also has for a goal to recruit and train a diverse body of students who will
represent the next generation of scholars in the science, technology, engineering, and mathematics (STEM).

Public health relevance
PROJECT NARRATIVE Our research goals are to understand why older individuals exhibit higher severity of and mortality from viral infections than younger adults. Our studies in the fruit fly Drosophila show that we can effectively model aged host-virus interactions in this genetically tractable organism and are using this system to identify the cellular and molecular mechanisms that underlie the capability of the aged organism to survive infection. At the long- term, this research could potentially lead to therapeutic improvements for infected elderly patients.